FASEB SRC on The Lung Epithelium in Health and Disease

The 2018 FASEB Summer Research Conference, The Lung Epithelium in Health and Disease, is the 10th biannual conference in this area, bringing together developmental, cell and molecular biologists, geneticists, physiologists, clinicians and translational researchers with a primary interest in lung epithelial biology. Selected topics are at the forefront of the lung search and the program is planned to disseminate new findings with translational potential. Topics include (1) molecular mechanisms of lung epithelial development and repair/regeneration, (2) common and unique pathways of intra- epithelial communications in lung physiology and diseases, (3) interactions between lung epithelium and innate and adaptive immune cells (4) cutting-edge genomic and gene expression analysis in epithelial-based lung diseases. In addition to the unique collection of research topics, this meeting provides a platform for new speakers, early stage investigators, and trainees. Twenty-two of 33 speakers (67%) have not spoken at this conference in the last four years, and thirteen of the 33 speakers (40%) are women, as well as half of the session chairs. Sixteen short-talk sessions are designated for trainees or new investigators. Specific efforts are being made to encourage participation by underrepresent minorities in the field. In addition to talks, there are 4 poster sessions and 4 “Meet-the-Experts” sessions to facilitate scientific and social interactions between all participants. By bringing the best of the lung epithelium research community together, the overall goal of this conference is to push the field forward towards innovative directions for basic research and novel therapeutics for important lung diseases, including asthma, chronic obstructive pulmonary disease, pulmonary fibrosis, and bronchopulmonary dysplasia.

Public health relevance
The 2018 FASEB Summer Research Conference, “The Lung Epithelium in Health and Disease,” is the primary forum for discussion of pulmonary epithelial science. The objective of the meeting is to stimulate meaningful discussion, facilitate collaboration and establish new research directions. This conference brings together basic scientists, translational researchers and clinician investigators to discuss state-of-the-art approaches to understand the molecular mechanisms which underlie a broad range of respiratory diseases such as asthma, bronchopulmonary dysplasia, chronic obstructive pulmonary disease, idiopathic pulmonary fibrosis, and others. By linking the pathobiology of these disorders to normal lung development and lung cell differentiation, common themes will be identified to provide a mechanistic understanding of these diseases and provide a powerful framework and validated platform for the development of novel therapeutic approaches.